Investigating the effectiveness of COVID-19 testing choices, community engagement, and culturally-embedded mHealth literacy delivery in a medically-underserved, community-based sample

Abstract
Uterine Fibroids (UFs) are monoclonal tumors arising in the myometrium, and are the most
common tumor of reproductive age women. An increasing body of evidence supports the
hypothesis that UFs originate from aberrant stem cells in the myometrium. We have now identified
a Stro-1+/CD44+ myometrial stem cell (MSC) capable of self-renewal and regeneration of
myometrial tissues, which gives rise to UFs in animal models. With our ability to identify and
isolate these MSCs, we are in a unique position to address how risk factors impact the UF
cell-of-origin to initiate and promote the development of these tumors.
Like many diseases, there is ample evidence that both environmental exposures and genetic
alterations contribute to UF pathogenesis. We, and others have shown that early life
environmental exposures to endocrine disrupting compounds (EDCs) increase UF risk by
inducing developmental reprogramming of the epigenome. Such epigenomic reprogramming
involves changes in histone and DNA methylation patterns that alter chromatin architecture and
gene transcription, and when induced in early life, persist into adulthood. Genetic alterations in
mediator 12 (MED12) and the tuberous sclerosis complex 2 (TSC2) tumor suppressor, drive
development of UF tumors in both humans and rodent models, respectively. Interestingly, MED12
and TSC2 defects share a common downstream effector: activation of β-catenin signaling and
TCF/LEF transactivation of gene expression.
Our previous inability to interrogate the cells-of-origin for UFs has limited our understanding of
how gene:environment interactions (GxE) influence UF risk. Now that we can isolate and profile
MSCs, we are for the first time in a position to overcome this critical barrier to understanding
determinants of risk for this important disease. In this application we will utilize our new-found
ability to isolate and interrogate MSCs, and apply recent insights on how environmental
exposures reprogram the epigenome, to explore GxE interactions that promote
tumorigenesis in the cell-of-origin for UFs.
Specific Aim 1: Test the hypothesis that activation of β-catenin signaling is a common
effector pathway for genetic alterations that drive UFs. In this mechanistic Aim, we will test
the hypothesis that in MSCs, MED12 mutation (human) or loss of Tsc2 (rat) results in an altered
transcriptional profile characterized by increased TCF/LEF transactivation of gene expression.
Specific Aim 2: Test the hypothesis that developmental EDC exposure results in epigenetic
reprogramming that cooperates with genetic defects in MSC/TICs. In this mechanistic Aim,
we will characterize EDC-induced reprogramming of the epigenome, and test the hypothesis that
reprogramming of TCF/LEF target genes exacerbates their expression when β-catenin is
activated in rMSCs and in tumor initiating cells (TICs).
Specific Aim 3: Test the hypothesis that MSCs associated with high vs low UF risk exhibit
differences in epigenetic histone modifications. In this translational Aim, we will explore the
relationship between MSC epigenetic patterns and UF risk using MSCs isolated from normal
myometrium of women without UFs (MyoN) and at-risk myometrium from women with UFs
(MyoF). Because epigenomic alterations are potentially reversable, we will also test the
hypothesis that an intervention that reduces UF risk does so by decreasing MSC number and/or
“resetting” the MSC epigenome back to a low risk profile.
Impact: Our work address several knowledge gaps and priority research areas as defined by NIH
including; Stem/Progenitor Cells in Gynecologic Health and Disease, Transdisciplinary Research
and '–Omics' in Gynecologic Disorders. Importantly, it will also be the first exploration of GxE
interactions that drive disease in the cells of origin for UFs.

Public health relevance
Project Narrative Uterine Fibroids (UFs, AKA: leiomyoma) are the most important benign neoplastic threat to women’s health. They are the most common cause of hysterectomy causing untold personal consequences and hundreds of billions of health care dollars worldwide. We have now identified specific markers for myometrial stem cell, the cell of origin of UF. With our ability to identify and isolate these stem cells, we are in a unique position to address how risk factors, such as African American race/ethnicity or early life environmental exposures promote the development of these common tumors. The overall goal of this proposal is to identify epigenetic mechanisms that promote development of UFs, and understand how they are modulated by known risk factors for this disease. These investigations are uniquely positioned to generate new paradigms for role of epigenetic alterations in the etiology of UFs that will have broad impact on the field and will provide novel therapeutic and preventive targets, leading to better non-surgical management options for women with, or at risk for uterine fibroids.